CLINICAL TRIALS INFORMATION MANAGEMENT SYSTEMS (CTIMS)

In order to incorporate emerging business and technical needs, further simplify and streamline the daily programmatic operations and business processes for stakeholders, and to further improve the leadership reporting capabilities, the new Clinical Trials Information Management Systems (CTIMS) technical suite is being established under this contract. The current information systems (CSOS, Clinical Dashboard, and eConnect) supporting the NHLBI clinical trials will be assessed, enhanced, modernized, streamlined and consolidated as needed for current and emerging needs.